Interorgan communication in aging in Drosophila

Project Summary/Abstract
Aging is a complex condition with diverse physiological effects ranging from the cellular to organismal levels,
such as the dysregulation of metabolism. While many distinct aspects of aging have been characterized, a
wholistic understanding of how these aspects function together will be necessary to define and treat age-
associated health decline and diseases more effectively. One way to address this is by better understanding the
inter-organ communication (IOC) that coordinates aging mechanisms between tissues. Our proposal focuses on
the IOC between aging metabolic tissues and how this communication alters metabolism and impacts biological
age. We propose a multi-omics approach of single-cell transcriptomics, tissue-specific proteomics,
metabolomics, and bioinformatics to work towards a system-level understanding of IOC, metabolism, and aging
in Drosophila melanogaster. We have recently generated the Aging Fly Cell Atlas (AFCA), the most
comprehensive single-cell transcriptomic dataset to-date of an entire aging organism. We will exploit and build
upon these data to identify novel IOC, tissue-specific metabolic reprogramming, and sex differences during
natural fly aging. Additionally, we propose system-level IOC and metabolomic characterization of 1) pro-longevity
models of mTOR inhibition in adult flies using tissue-specific FoxO activation and rapamycin feeding and 2)
advanced aging models of degenerative muscle stress and human Tau-induced neurodegeneration. We will
correlate findings from these models with those from the AFCA to discover anti-aging targets within the IOC
network that will modulate aging metabolism in a tissue-specific fashion. This work has the potential to 1) better
understand how organismal metabolism is regulated via IOC; 2) develop strategies to enhance anti-aging
therapies such as rapamycin; 3) identify disease mechanisms of muscle and neural degeneration that affect
otherwise healthy distant tissues; 4) ultimately elucidate fundamental system-level aging biology and accelerate
the discoveries of new anti-aging therapies.

Public health relevance
Project Narrative Understanding aging as a systemic process of coordinated changes across organs requires a multifaceted and wholistic research strategy. We will use a comprehensive multi-omics approach of single-cell transcriptomics, metabolomics, proteomics, and bioinformatics to elucidate networks of inter-organ communication that alter metabolism in models of anti-aging, pro-aging, and natural aging in Drosophila.